Gadgetron Global Network and Intelligence Computing: Clinical Imaging Application Development and Software Infrastructure

The past FY of 2024-2025 saw many development of imaging AI and Gadgetron projects:

a) Imaging foundation model is being developed with Gadgetron global network data support.

b) Imaging transformer model is developed to support large training and show impressive capacity to boost image quality, shorten acquisition and improve resolution.

c) Agreements were established with multiple sites to let NHLBI keep and use anonymous data for research purpose and beyond.

d) Invented methods to calibrate models and showed imaging transformer improve SNR without sacrificing spatial resolution.

e) continued technical developments in quantitative CMR perfusion to improved the accuracy and precision of estimates